Yale-SCORE Leadership Administrative Core

LEADERSHIP ADMINISTRATIVE CORE ABSTRACT
The purpose of the Leadership Administrative Core is to provide overall interdisciplinary and translational
scientific planning and coordination for the Yale-SCORE as it develops therapeutics for the treatment of
alcohol use disorder (AUD) that are responsive to sex differences. The Core provides structure and resources
to: manage the ongoing conceptual integration of Center personnel to capitalize on synergies and translational
opportunities for the Yale-SCORE; support the development of new collaborative research within the Yale-
SCORE and with other Yale centers, and SCOREs at other institutions; organize regular planning meetings to
promote dynamic exchange among investigators regarding new scientific findings and their implications for
medications development for AUD; and, convene and coordinate the functions of the Internal and External
Advisory Boards. The goal for the Advisory Boards is to provide valuable insights, feedback, and
recommendations to ensure the Center's scientific rigor, relevance, and impact. The Core provides fiscal and
administrative management for all components; participates in evaluation of applications for pilot projects in
conjunction with the Career Enhancement Core; participates in the training, education, and mentorship
activities outlined in the Career Enhancement Core; oversees the distribution of research-related resources
provided in the Resource Support Core; provides input into the design of the core assessment battery to
maximize the scientific yield across Yale-SCORE Projects and Pilots, other Yale Centers, and SCOREs at
other institutions; and helps to disseminate our findings through educational outreach to local, regional, and
national audiences of health care professionals and consumers. Finally, we continue to build our presence as
an institutional, regional, and national resource to invigorate and galvanize the study of sex differences focused
on alcohol science.

Public health relevance
LEADERSHIP ADMINISTRATIVE CORE NARRATIVE Rates of alcohol-related mortality have recently and concerning increased in women. The Leadership Administrative Core advances the public health effort to improve AUD treatment by providing key infrastructure to support an integrated scientific environment focused on the development of treatments for AUD that target factors which maintain drinking in women, namely stress and negative affect.